Regulation and Function of ZEB1 Dimerization in Lung Adenocarcinoma Progression and Metastasis

Project Summary/Abstract
Non-small cell lung cancer (NSCLC) is the leading cause of cancer-related death worldwide due to the ability of
cancer cells to metastasize. Epithelial-to-mesenchymal transition (EMT) is a mechanism for metastasis, which
results in a loss of apical-basal polarity and specialized epithelial cell contacts to acquire mesenchymal migratory
capacity and invasiveness. The Zinc finger E-box binding homeobox 1 (ZEB1) transcription repressor recognizes
and binds E-boxes of gene promoter regions to suppress the expression of epithelial genes such as E-cadherin.
ZEB1 recruits transcriptional corepressors and, in fact, we have recently reported that ZEB1 interacts with
histone deacetylases (HDACs) 1 and 2 containing nucleosome remodeling and deacetylase (NuRD) complex to
regulate the transcription of their target genes. ZEB1 has a predicted molecular weight of 125 kDa; however,
several groups have reported inconsistencies in the observed molecular weight (approximately 190-220 kDa),
which has been attributed to post-translational modifications (PTMs). To date, the regulation of molecular
associations and functions, as well as the discrepancy between the predicted and observed ZEB1 molecular
weight, is still unclear. Previous data from my lab shows that both murine and human NSCLC cell lines treated
with class I HDAC inhibitors reduce the molecular weight of ZEB1 from 250 kDa to 125 kDa. Additionally, through
co-immunoprecipitation, we demonstrated that ZEB1 forms a homodimer that is dependent on class I HDAC
activity. Therefore, we performed mass spectrometry and identified a novel PTM - K811 acetylation - that may
regulate ZEB1 dimerization, protein interactions, and/or stability. Consequently, we sought to define the role of
ZEB1 acetylation in dimerization and activity by generating ZEB1 acetyl mimetic (K811Q) and deficient (K811R)
mutants in NSCLC cell lines. We hypothesize that ZEB1 acetylation regulates its dimerization via the NuRD
complex, which subsequently promotes NSCLC metastasis. We will address this hypothesis by: i) determining if
ZEB1 dimerization and protein stability are regulated by acetylation, ii) evaluating whether homodimerization
contributes to ZEB1/NuRD-mediated transcriptional repression, iii) assessing the functional effect of ZEB1
dimerization in NSCLC metastasis. Our data demonstrated that the acetyl-deficient mutant (125 kDa) exhibits a
decreased half-life compared to wild-type and acetylated ZEB1 (250 kDa), suggesting that disruption of
acetylation hinders protein dimerization and stability. Intriguingly, we previously reported that ZEB1 preferentially
forms a complex with NuRD in NSCLC cell lines; however, the significance of the physical association between
ZEB1 dimers with the NuRD complex to regulate its metastatic function has not been identified. Accordingly,
under the mentorship of Dr. Don Gibbons and Dr. Michelle Barton, I aim to characterize the contribution of ZEB1
dimer/NuRD-mediated transcriptional repression and to facilitate the development of alternative therapeutic
strategies targeting PTMs with the ultimate goal of improving the survival of lung cancer patients.

Public health relevance
Project Narrative ZEB1 is a well-defined transcription factor of metastatic progression and chemotherapy resistance in multiple tumor types. We identified a novel post-translational modification - K811 acetylation - that may regulate ZEB1 dimerization, protein interactions, and/or stability. In this research proposal, we will characterize the molecular mechanisms by which ZEB1 acetylation regulates its dimerization via the NuRD chromatin remodeling complex, with the goal of identifying its functional and pathological relevance for the metastatic process.